1) EXERCISE ADDITIONAL "UP-TO HOURS" DURING OPTION YEAR TWO (2)2) REVISE ATTACHMENT 2: OTHER TERMS AND CONDITIONS, P.4, HHSAR 352.237-75 KEY PERSONNEL TO SUPPORT THE NIMH NDA WHICH IS A SINGLE DATA

1) EXERCISE ADDITIONAL "UP-TO HOURS" DURING OPTION YEAR TWO (2) 2) REVISE ATTACHMENT 2: OTHER TERMS AND CONDITIONS